AMITRIPTYLINE IN THE RELIEF OF OROFACIAL PAIN, DEPRESSION AND SLEEP DISORDERS

The project is evaluating the analgesic efficacy of amitriptyline at two doses in comparison to placebo for the mamagement of chronic orofacial pain; to determine an optimal dose to be used; and to determine the mechanism of action of antidepressants in pain management. A double-blind incomplete cross-over design of drug administration is used and each subject is administered in two four-week periods, separated by a two week washout, one of the following: placebo, high dose amitriptyline, or low dose amitriptyline. Both high dose (up to 150 mg) and low dose (10-30 mg) of amitriptyline result in significant pain relief in comparison to placebo. Amitriptyline reduced depression scores in the depressed patients but not in non-depressed patients, providing evidence that its analgesic effect is not associated with a parallel change in mood.